Proposed Meal Changes for CACFP: Impact on Child Food Intake and Costs

DESCRIPTION (provided by applicant): Revised Federal School Meal Guidelines: Impact on Student Food Intake and Costs CACFP meals are an important influence on diets of children from low-income families enrolled in the CACFP and should meet children's nutrient needs while fostering healthy eating habits that enable them to maintain energy balance. Recent national data revealed that children consumed low intakes of foods that support healthy dietary patterns (whole grains, fruit and vegetables other than potatoes), but high intakes of low nutrient, energy dense foods. The 2011 USDA-commissioned Institute of Medicine (IOM) report for CACFP meals provided new recommendations that include new meal pattern requirements for the meals programs, aligning them with the U.S. Dietary Guidelines to ensure that the meals promote health and reduce inadequate and excessive intakes. The report recommended inclusion of more whole grains, fruit, vegetables, and meat/meat alternatives which will likely increase meal costs. Two of the IOM report recommendations call for research to better understand how the new meal requirements would change children's CACFP meal dietary intakes and food service costs. These are important questions, and answers are needed to inform policy and future technical and educational assistance needs. The overall objective of this R01 grant application is to implement the IOM meal pattern requirements for CACFP meals in day homes and centers in Texas. Our multidisciplinary team will focus on nutrition, economics, and provider outcomes. The specific aims are to assess the impact of the new meal pattern requirements on 1) Meal participation rates; 2) Provider food service costs (food, labor, total meals); and 3) Child dietary intake at CACFP homes and centers. We hypothesize that, compared with control schools; intervention school students will select and consume healthier diets (more fruit, vegetables and whole grains) at school. We will collaborate with the Southwest Human Development Services, Inc. and recruit a total of 16 day care homes and 16 day care centers for the proposed study. We hypothesize that, compared with control sites; children at the intervention sites will select and consume healthier diets (more fruit, vegetable and whole grains) at the center. We also hypothesize that the increase in food costs will be less than that projected in the IOM report. The results on the costs associated with creating the desired meals will be very important as these data have not been systematically collected in previous studies. This significant study targets underserved minority populations with health promoting intervention to reduce health disparities, and in addition, will inform policy on the influence of healthy food environment on children's diet, as well as provide critical information on costs.

Public health relevance
PUBLIC HEALTH RELEVANCE: This application will implement the new IOM meal pattern requirements for CACFP meals promoting whole grain, fruit, vegetables, and meat/meat alternatives in day care centers and homes. Outcomes from this study will identify what changes in children's dietary behaviors occur at CACFP mealtime as a result of the new meal patterns, identify the financial impact on the meal cost, and inform policy.